Research Training in Anesthesiology and Pain Medicine

Project Summary/Abstract
Modern anesthesiology and pain medicine have increasingly become an interdisciplinary specialty of medicine
that requires integrated knowledge in anesthesiology, critical care medicine, neurobiology, pharmacology,
structural and computational biology, pulmonary physiology, and molecular biology and genetics. This
competitive renewal application seeks funding for years 16-20 of our successful T32 training program in
postgraduate anesthesia research training at the University of Pittsburgh. Our primary goal is to continue training
physician scientists to lead the future intellectual pursuits in anesthesiology beyond the confines of the traditional
provision of anesthesia and to become independently funded investigators and leaders in the field. The trainees
from our previous funding cycles have demonstrated success in this path, producing numerous peer-reviewed
publications, achieving seed, startup, foundation, and NIH K- and R-level grant funding, and presenting at
scientific conferences. We propose to add two fellows each year in Years 16-20 and hence request four training
slots per year to ensure a minimum of two-year training for each fellow. A team of 35 principal training faculty
with excellent training records and successful research programs funded by the NIH and other agencies have
been carefully selected. A new cohort of six junior training faculty (five are alumni of this training program) will
be paired with more senior faculty to actively participate in the mentoring of our future trainees. Programmed
training and research activities will target anesthesiology-related problems defined in the broadest sense. The
planned two-year training will combine structured didactic and interactive teaching on both a group and individual
basis, as well as one-on-one mentoring in laboratory/clinical research. Multiple courses and online training
sessions in research integrity and scientific rigor are mandatory for all trainees. Departmental, institutional, and
programmatic efforts are established to actively recruit underrepresented minority trainees and people with
disabilities into the program. A supportive mentoring environment ensures the retention and career advancement
of these trainees. The administrative infrastructure consists of the Oversight Committee led by the Chair of the
Department of Anesthesiology and Perioperative Medicine and the Executive Committee chaired by the Program
Director. The Executive Committee, working closely with the trainees and the training faculty, will be in charge
of the selection, appointment, and assignment of the trainees, and manage the review and evaluations of the
training faculty and trainees. Continuation of NIH support to this postdoctoral training program, which focuses
primarily on training physician scientists, will provide both unique opportunities and critically needed resources
for the next generation of academic anesthesiologists to integrate multidisciplinary knowledge from the bench-
top to the bedside.

Public health relevance
Project Narrative Each year in the US, anesthesiologists provide indispensable professional services in ~50 million medical procedures and treat acute and chronic pain associated with these procedures and many diseases such as cancer. The very best physician scientists are needed to lead the future intellectual pursuits in anesthesiology and pain medicine and to translate research findings into improved clinical outcomes. The proposed Kirschstein National Research Service Award Program at the University of Pittsburgh will continue the successful tradition of creating the best possible academic environment and opportunities to train anesthesiologists and postdoctoral research scientists to become leaders in the field of anesthesiology and perioperative medicine.